Involvement of habenulo-interpeduncular circuitry in nicotine reward and aversion

Project Summary/Abstract
Smoking tobacco is one of the leading causes of preventable mortality in adults worldwide. However, there is
currently a lack of pharmacological smoking cessation aids and their efficacy is limited. Therefore, there is an
urgent need to better understand the neural mechanisms that underlie nicotine addiction for the development of
novel smoking cessation treatments. Much of our understanding of the reinforcing effects of nicotine are derived
from studies focused on canonical mesolimbic dopamine reward circuitry in the brain. Research suggests that
the habenulo-interpeduncular pathway consisting of the medial habenula (MHb) and interpeduncular nucleus
(IPN) contributes to the aversive motivational properties of high nicotine doses. It is speculated that activation of
nicotinic cholinergic receptors (nAChRs) stimulates excitatory acetylcholine/glutamate (ACh/Glu) co-releasing
projection neurons which activate ɣ-aminobutyric acid (GABA) neurons in the IPN. However, silencing IPN
neurons in rodent models has also been shown to reduce nicotine consumption and reward. Thus, it is possible
that modulation of MHb→IPN circuit activity may contribute to the balance of nicotine reward and aversion, a
critical component of nicotine addiction liability. However, it is unknown how MHb→IPN neurons respond to
nicotine within the context of reward related behavior. It is also unclear whether nicotine-induced activation of
this circuit is necessary to elicit nicotine’s aversive properties. In the proposed project, I aim to test the hypothesis
that modulation of IPN GABAergic neuron activity by nicotine is critical for balancing nicotine reward/aversion. I
also aim to test the hypothesis that nicotine-induced control of ACh/Glu projection neuron activity from the MHb
to IPN controls nicotine reward/aversion balance. Thus, I will assess the influence of rewarding or aversive
nicotine doses on MHb or IPN neural activity during the performance of conditioned place preference/conditioned
place aversion (CPP/CPA) procedures using in vivo fiber photometry combined with genetically encoded calcium
indicators (GCaMPs). Finally, I will use in vivo optogenetics to selectively activate or silence MHb or IPN neurons
to investigate whether specific components of this circuit are sufficient to drive nicotine reward/aversion balance.
The goal of this project is to provide a better understanding of circuit-specific mechanisms that may contribute
to nicotine reward/aversion balance, which will aid in the development of precise pharmacological treatments for
smoking cessation.

Public health relevance
Project Narrative Although smoking tobacco is a leading cause of preventable mortality in adults worldwide, there are few pharmacological smoking cessation aids available and their efficacy is limited. The habenulo-interpeduncular pathway represents an understudied brain circuit that has been found to be involved in nicotine withdrawal symptoms and the aversive motivational properties of nicotine; however, the effects of nicotine on this circuit within the context of reward-related behavior is unknown. Results from this project will elucidate specific neurophysiological mechanisms of nicotine reward/aversion balance within the habenulo-interpeduncular circuit in freely behaving animal models which will contribute to the development of precise treatments for nicotine addiction.